Histone Expression in the Aging RPE

Project Summary (30 lines):
Aging is a complex, multifactorial process wherein transcriptional reprogramming is accompanied by
perturbations in the epigenome. We have performed experiments to determine the histone expression profile
in the aging RPE and discovered an age-dependent loss of histone expression that was specific to the RPE.
It is not known whether loss of histone expression during RPE aging alters gene expression, induces cell
death, or leads to the progression of age-related macular degeneration (AMD). AMD is a blinding disease that
is hallmarked by the death of retinal pigment epithelium (RPE), choroidal neovascularization, and loss of the
overlying photoreceptors in the central retina. Several recent scientific advances have revealed an array of
molecular mechanisms that result in RPE atrophy including disinhibition of the alternate complement pathway,
inflammasome activation, and the expression of pro-apoptotic signaling components Tight
histone
which
serve
expression
to
histone
be
regulatory
regulation of
expression is essential to maintain chromatin structure and appropriate gene expression profiles
are critical to cell viability and function. Moreover, post-translational modifications (PTM) of histones
as critical mechanisms for epigenetic regulation of gene expression. Decreased histone gene
and altered histone PTMs have been identified as a molecular hallmark of aging. The Objective is
define signatures of histone expression in the aging RPE and determine the cellular effects of loss of
expression in RPE homeostasis and AMD progression. The Hypothesis is that histone depletion may
a key factor contributing to RPE aging and senescence and that therapeutic targeting of key histone
mechanisms ma serve as a valuable approach to reverse aging and senescence in the RPE. Using
RNA-seq, ChIP-seq, high-throughput screening of histone PTMs, Western blotting, and immunofluorescence
SA1
homeostasis
blotting,
RPE
histone
whether
and
further
in
and
evaluates histone expression profiles and marks to identify critical regulatory factors o histone
in the aging mouse RPE. Using RNA-seq, high-throughput screening of histone PTMs, Western
and immunofluorescence, and immunohistochemistry, SA2 i nterrogates in vitro models of human
aging, aged normal human eyes and eyes with advanced dry AMD for loss of histone expression,
modifications, and molecular mechanisms of histone related cell death. Further work will demonstrate
restoration of specific histone isoforms or histone regulatory factors will reverse aging, senescence
restore RPE cell viability in mouse and cell culture models. These data will be critical to developing
scientific insight into the critical role of tightly regulated histone gene expression in the aging RPE and
AMD progression while offering a novel therapeutic approach to maintaining RPE health, genomic fidelity,
cellular integrity.
f

Public health relevance
Project Narrative: Age-related macular degeneration (AMD) is the most common cause of irreversible vision loss in the world. The scientific understanding of the aging retinal pigment epithelium (RPE) and molecular mechanisms that trigger AMD progression and RPE cell death are critical to discovering potential therapeutic targets for this blinding disease. This proposal will determine signature of histone expression during RPE aging and the impact on RPE gene expression, RPE cell death, and AMD progression.